Environmental modulation of maternal behavior and mesolimbic DA function

PROJECT SUMMARY
In humans, postpartum stress exposure is associated with increased risk for mood disorders and compromised
quality of mother-infant interactions (i.e. maternal care). For example, mothers that undergo postpartum adversity
may lose interest in their babies and have difficult caring for their infant’s needs. However, the neural
mechanisms by which adverse maternal environments contribute to aberrant maternal behavior remain poorly
understood. One potential pathway is the mesolimbic dopamine (DA) system, which originates in the ventral
tegmental area (VTA) and is critically involved in reward-related processes, including maternal behavior, and the
pathophysiology of depression. Importantly, DA dysregulation has been observed in women with PPD and
studies in rodent models relevant for the study of depression have shown a causal link between DA system
dysregulation (i.e. decreased VTA DA neuron activity) and negative affect-related behaviors (i.e. anhedonia,
passive coping). Thus, compromised activity of VTA DA neurons induced by postpartum adversity may interfere
with reward-related processes necessary for maternal motivation and responsiveness. Yet, little is known about
the regulation of DA system function in postpartum rodents at baseline and under conditions of adversity. The
overall goal of this proposal is to determine the impact of an adverse postpartum environment, as modeled by
providing the dam with limited bedding and nesting (LBN) materials from postpartum days 2-9, on maternal
behaviors and mesolimbic DA function while testing a mechanistic role for the stress hormone corticosterone
(CORT) (Aim 1). This work will lay the necessary groundwork for future experiments aimed at conducting cell-
type specific in vivo optical recordings of genetically identified VTA DA neurons during the expression of maternal
behavior in adaptive (control) and maladaptive states (LBN) over time, while also enabling assessment of time-
locked behavior/DA responses (Aim 2), and causally manipulating potential neural circuits driving LBN-induced
alterations in VTA DA function (Aim 3). Importantly, these aims are based on my preliminary data showing
disrupted mother-infant interactions and attenuated VTA DA activity in LBN dams. During the award period, I will
use an integrated systems-oriented approach including behavioral assays, hormonal measurements, in vivo
electrophysiology and fiber photometry, and chemogenetic approaches that enable causal manipulations of
specific cells and circuits involved in the regulation of VTA DA activity. This proposal addresses an important
gap in knowledge, is consistent with the NIMH’s mission to increase research in females to improve women’s
mental health, while enabling me to acquire new conceptual, technical, experimental and analytical skills
(through the help of my Advisory Team/Co-Mentors) that will help me launch an independent research career.

Public health relevance
PROJECT NARRATIVE Maternal behavior is impaired under conditions of chronic stress and/or adversity as well as in postpartum mood disorders. This application will examine the impact of postpartum adversity (as modeled through environmental resource depletion) on motivated maternal behaviors and mesolimbic dopamine function in the rat dam by employing an integrated approach (e.g. environmental perturbation, behavior, in vivo electrophysiology, optical recordings of genetically identified cells via the use of transgenic animals and in vivo fiber photometry, circuit- specific manipulations using DREADDs). In this way, I hope to provide insights into mesolimbic DA mechanisms contributing to adversity-induced alterations in mother-infant attachment.